Comparative effectiveness of balanced fluids versus normal saline to reduce acute and chronic kidney disease in children with sepsis

PROJECT SUMMARY
Acute kidney injury (AKI) is a risk factor for adverse outcomes in critically ill children, including prolonged
hospitalization, disability, and death. AKI is particularly significant for children with sepsis, a medical emergency
due to life-threatening organ dysfunction from infection that affects over 72,000 children in the US and four million
children worldwide each year. Children with sepsis-induced AKI and acute kidney disease (AKD, persistent
kidney dysfunction of <90 days duration) may also be at risk for chronic kidney disease (CKD). Specific risk
factors for AKI and CKD among children with sepsis remain poorly defined and, importantly, gaps remain in
identifying the best therapies to prevent sepsis-induced AKI, AKD, and CKD. Crystalloid fluid, the cornerstone of
resuscitation for septic shock, has key biological effects on kidney function. Emerging data in adults suggest that
resuscitation with 0.9% “normal” saline (NS) is more likely to induceAKI and AKD compared to resuscitation with
balanced fluids (BF). Few data on the impact of fluid resuscitation on kidney function in children exist. In this
study, we will perform an ancillary study to the PRagMatic Pediatric Trial of Balanced vs. nOrmaL saline flUid in
Sepsis (PRoMPT BOLUS) randomized clinical trial. That trial is randomizing children in emergency departments
with suspected septic shock to fluid resuscitation with either NS or BF. The trial will determine the comparative
effectiveness of different crystalloids on 30-day kidney function and death in children with suspected septic
shock. However, data on outcomes such as AKI or CKD will not be collected in direct follow-up of trial
participants. A remaining knowledge gap after trial completion will therefore be whether BF resuscitation in
pediatric sepsis protects against AKI and translates to a decrease in CKD. To assess these important kidney
outcomes, we will use the Pediatric Center of Excellence in Nephrology (PCEN) Learning Health System Core
to link clinical trial data to electronic health record data available in PEDSnet (pedsnet.org) to augment trial
outcome analyses. The primary objectives of this study are to: 1) assess whether resuscitation with BF instead
of NS will decrease AKI and translate to a decrease in CKD in trial participants, and 2) measure the real-world
impact of crystalloid fluid choice on sepsis-induced AKI and CKD in the larger PEDSnet source population. To
achieve these objectives, we will utilize electronic health record data in PEDSnet to measure AKI and CKD in
2,450 children enrolled in the PRoMPT BOLUS study at 7 trial sites. To demonstrate generalizability of trial
results using a real-world comparison, we will determine the impact of crystalloid fluid exposure on AKI and CKD
in a broader cohort of over 16,600 children in PEDSnet presenting to an ED for treatment of septic shock using
a quasi-experimental observational study design. We will also determine other risk factors for progression from
AKI to AKD to CKD in children with sepsis. This proposal aligns with the PCEN goal to facilitate extensive
collaborative research around the causes, diagnosis, and treatment of kidney diseases in children with increased
efficiency and NIDDK’s mission to evaluate treatments to prevent the development of kidney disease.